Development of New Proteomics Technology and its Application to Study Cellular Organization

Development of New Proteomics Technology and its Application to Study Cellular Organization
The broad goal of our lab is to obtain a systems-level understanding of cellular organization and develop
proteomics technology that facilitates this research. Thanks to the human genome project, we have a nearly
complete parts list of all molecules making up cells, but we still very poorly understand how these molecules
come together and elegantly organize into a living system. So far, this organization has been studied mainly by
looking carefully at one protein at a time. While this approach has been tremendously successful, it cannot
address the higher levels of complexity in biological systems that arise from the interplay of a myriad of
components. Looking at one molecule at a time can severely hinder understanding biology. Instead, we
investigate the entire system all at once. Recent progress in multiplexed proteomics enables us to observe
thousands of proteins simultaneously among multiple conditions. Combined with classical biochemical
approaches, we can reveal collective behavior and emergent properties that we would not have discovered
otherwise. My lab is broadly interested in systems-level cellular organization. Towards this goal, this proposal
contains two parts.
The first part of this proposal outlines how we intend to improve quantitative proteomics technology.
Proteomics has become very powerful. Nevertheless, severe shortcomings concerning sensitivity, data quality,
and accessibility remain. We strive to address these problems. Over the last year, we have developed a new
method for quantitative shotgun proteomics (TMTproC), producing data with unmatched sensitivity and
measurement quality while reducing cost. Next, we aim to make TMTproC compatible with entry-level mass
spectrometers, which has the potential to democratize quantitative proteomics. Furthermore, we propose to fuse
TMTproC with data-independent acquisition (DIA). We anticipate that this will fuse the benefits of both
approaches: a method delivering the exquisite measurement quality of multiplexed proteomics with the infinite
scalability of DIA.
The second part describes how we aim to apply our technological advances toward understanding
systems-level mechanisms. First, we will integrate passive diffusion and active transport models through the
nuclear pore to predict how the entire proteome partitions between the nucleus and cytoplasm. Second, we aim
to integrate all levels of protein abundance control aspects for every gene – transcription, translation, and protein
degradation. We will focus on protein turnover, the technically most difficult to measure of these parameters.
Ultimately, we aim to determine how protein expression levels are controlled for each gene as a fertilized zygote
develops into an embryo with a fully defined body plan. These measurements will provide us with fundamental
insight into the regulation and organization of developing embryos in health and disease.

Public health relevance
Project Narrative We aim to develop new technology to quantitatively analyze thousands of proteins in a single experiment, which will be widely beneficial to studying biological systems in health and diseases. We will apply these techniques to study how proteins partition between the nucleus and cytoplasm and to measure how proteins are degraded. This study will provide us with insight into how healthy and diseased cells control their protein abundance levels and determine protein subcellular localization.